Motion-Robust Iron Quantification of Newborn Brains using Radial MRI

Iron plays a vital role in brain development, contributing to processes such as synaptogenesis, myelination,
and neurotransmitter synthesis. Perinatal iron deficiency has been linked to delayed nerve conduction,
impaired recognition memory, motor difficulties, and lower overall developmental scores. Preterm births affect
about 1 in 10 U.S. infants, and 25 - 85% of them show signs of iron deficiency during infancy. Accurate
measurement and timely supplementation of brain iron during this early critical phase is therefore essential for
optimizing neurodevelopmental outcomes. Qutantitatve susceptibility (QSM) and R2* MR imaging have proven
to be important tools for the non-invasive quantitative measurement of brain iron levels. However, these
techniques have not yet been robustly deployed in infant studies, especially those preterm infants. The key
challenges include: 1) Traditional Cartesian imaging techniques are lengthy (>10 mins) for neonates and highly
motion-sensitive; 2) Motion-induced geometric and field distortions introduce additional phase errors,
compromising quantitative accuracy; 3) Standard QSM captures average susceptibility within each voxel,
making it difficult to separate iron (positive susceptibility) from myelin (negative susceptibility) in the neonatal
brains. To address these challenges and enable the reliable use of quantitative MRI techniques to study iron
deficiency of neonatal brains, we propose motion-robust 3D kooshball data acquisition and advanced
reconstruction strategies for rapid high-resolution QSM and R2* imaging of neonatal brains. In Aim 1, we will
extend an existing 3D radial sequence to incorporate multi-echo readouts, adapting previously developed
motion estimation algorithms that extract brain motion and motion-induced field maps from the data itself. We
will further design an image space-based reconstruction algorithm to generate high-quality MR images from
undersampled radial data. In Aim 2, we will develop and validate a motion-corrected, deep-learning-
regularized model-based nonlinear reconstruction algorithm that directly estimates quantitative maps from
highly undersampled radial data using our rapid protocol from Aim 1, significantly reducing the imaging time.
In Aim 3, we will apply source separation techniques to distinguish iron (positive) and myelin (negative)
susceptibility from the estimated QSM maps using R2* and R2 information. We will perform evaluation of the
utility of the developed technologies in assessing brain iron development in preterm neonatal subjects with iron
deficiency compared to full-term neonates. To that end, our novel technologies would speed up the quantitative
MR exams and allow for accurate and reliable iron quantification of newborn brains.

Public health relevance
PROJECT NARRATIVE Perinatal iron deficiency is associated with delayed nerve conduction, motor difficulties, and lower developmental scores, with 25–85% of preterm newborns showing signs of iron deficiency during infancy. Quantitative susceptibility mapping (QSM) and R2* MRI offer promise for non-invasive measurement of brain iron levels, but conventional methods are lengthy and highly motion-sensitive, limiting their use in infant studies. We propose a novel imaging method to enable high-quality brain iron quantification in newborns, incorporating motion-robust data acquisition, deep-learning-enhanced image reconstruction, and advanced data analysis techniques.